Automated technology for the preservation of Drosophila embryos

PROJECT SUMMARY Drosophila research labs routinely maintain hundreds to thousands of unique strains.
Not only is this practice labor and resource intensive, but there is a risk that valuable strains will be lost,
contaminated, or acquire additional mutations. This limitation would be overcome by the implementation of
Drosophila cryopreservation methods. Cryopreservation of Drosophila embryos was first reported nearly 30
years ago, with subsequent optimization that enables preservation of both wild type and transgenic lines. Broad
implementation of these cryopreservation technologies has not yet been realized. This may be due in part to
complex methodologies utilizing toxic solvents and desiccation steps required to permeabilize the embryos to
cryoprotective agents (CPAs). Recently, our lab has developed an embryo permeabilization solution that is free
of harsh solvents, does not require desiccation or manual mixing, and has been semi-automated using syringe
pumps. We have demonstrated in preliminary data that this approach successfully enables cryopreservation of
Drosophila embryos that develop into adults and produce offspring. In the present technology driven proposal,
our overall goal is now to develop a fully autonomous fluidic device capable of performing all liquid handling
steps (i.e. dechorionation, permeabilization and CPA loading) required in the cryopreservation protocol. Here,
no external computers or mechanical systems are required, as the device automatically times and performs
liquid handling using only power from house vacuum lines. This is significant, as it eliminates high upfront costs
associated with the fluidic system, reduces user-error, requires less labor and resources, and can be multiplexed.
We anticipate this approach will result in an accessible, affordable technology that can be broadly implemented
by the research community regardless of laboratory size or operating budget.
Key deliverables for this focused technology award include i) a robust and simple chemical process that enables
permeabilization and CPA uptake in Drosophila embryos and ii) an autonomous fluidic device that enables
precise timing and delivery of reagents. The scientific team is well-suited to perform the work described in this
proposal and includes experts in chemistry and cryobiology (Sandlin), Drosophila biology (White) and
engineering (Toner). Our work will be completed through three specific aims. In Aim 1, we will focus on
optimization of the chemical process for the cryopreservation procedure (e.g. permeabilization, CPA loading,
etc.). In Aim 2, we will fabricate and validate the fluidic device to achieve full automation of complex liquid
handling steps. In Aim 3 we will complete a validation study and disseminate the technology. Specifically, we
will integrate best practices from Aims 1/2 to validate the fully automated procedure against a larger panel of
Drosophila strains. Our goal is to maintain ≥60% survival of thawed embryos to adults relative to non-preserved
controls. We will further work with three outside Drosophila labs to identify and address variables that may
impact full use and broad implementation of this technology.

Public health relevance
PROJECT NARRATIVE Drosophila is an important model organism used extensively in evolutionary and developmental biology studies. Drosophila research laboratories often maintain hundreds to thousands of genetically modified stocks, requiring routine maintenance and risk of strain loss or genetic drift. The goal of this project is to develop autonomous cryopreservation methods for Drosophila, such that strains can be banked indefinitely and available for on- demand use.